The Second Heart Field in Lymphovenous Valve Development: Understanding Lymphatic Dysfunction in Congenital Heart Disease

PROJECT SUMMARY
As the most common birth defect, congenital heart disease (CHD) is a prevalent health concern. Some of the
most severe and life-threatening CHD arise in the arterial pole, where a subpopulation of mesodermal
progenitors called the second heart field (SHF) contribute to the myocardium of the outflow tract and right
ventricle. Children with CHD are prone to debilitating lymphatic conditions including plastic bronchitis,
lymphedema, chylothorax, and protein-losing enteropathy. However, insufficient research into the lymphatic
system in the context of CHD has been conducted. To determine the basis of lymphatic dysfunction in patients
with CHD, I focus on understanding the development of the bilateral bicuspid lymphovenous valves (LVVs),
through which interstitial fluid collected by lymphatics drains into the venous circulation. LVVs are necessary
gatekeepers at the junction of lymphatic ducts with veins and their absence results in primary lymphedema and
blood-filled lymphatics. Our preliminary data suggest that the SHF contributes not only to cardiomyocytes but
also to LVVs. I expect this work will establish the SHF as a common precursor of the lymphatic and
cardiovascular systems. Through my specific aims, I plan to determine 1) when SHF-derived cells contribute to
developing LVVs and if they do so through a venous intermediate and 2) if this contribution is required for proper
LVV formation. In my first aim, I will use constitutive and inducible Cre-loxP technology, intersectional fate
mapping, and immunofluorescence staining of mouse embryos to genetically trace SHF cell lineage and fate
map SHF progenitors. In my second aim, I will utilize conditional knockout mouse models and
immunofluorescence staining to determine if SHF progenitors are required for LVV development. I will investigate
if defects in the SHF precipitate abnormal LVV development in a mouse model of the human disease 22q11DS,
which presents clinically as SHF-related heart defects and can be accompanied by lymphedema. Completion of
the studies described in this proposal will provide novel insight into the development of lymphatics, the cellular
origin of the LVVs, and lymphatic defects in CHD patients. My findings will lead to improved screening and
treatment of potentially life-threatening lymphatic defects in CHD patients.
The proposed project will be carried out in a well-equipped laboratory at Rutgers New Jersey Medical School,
guided by a sponsor with a strong record of research contributions to vascular development in the context of
congenital heart disease. The sponsor has mentored numerous graduate students to success and brings a
wealth of experience to the project. The PI will utilize her previous training in developmental biology,
supplemented by new skills in lineage tracing and quantitative analysis of three-dimensional confocal datasets.
Her training plan outlines achievable objectives in field-specific research training, dissemination of findings,
clinical experience, mentoring, and professional development.

Public health relevance
PROJECT NARRATIVE Patients with congenital heart disease, the most common human birth defect, are prone to lymphatic dysfunction. Some common forms of congenital heart disease result from disruption of the second heart field, a group of progenitors necessary for right heart and outflow tract formation. I propose to investigate the necessity of the novel contribution of the second heart field to developing lymphovenous valves and therefore establish a potential developmental basis for the co-occurrence of congenital heart and lymphatic defects.